Functional Genomics of Multiple Hereditary Exostoses

Multiple hereditary exostoses (MHE) is an autosomal dominant disorder that affects one in every 50,000 children
worldwide and is characterized by the formation of cartilage-capped osteochondromas, known as exostoses,
adjacent to the growth plates of long bones and other skeletal elements. Due to their location and size, exostoses
can cause skeletal deformities, growth retardation, chronic pain, and undergo malignant transformation in ~5%
of the patients. Currently, there are no approved treatments for this disorder besides surgery and pain
management; therefore, there is an urgent need to discover novel therapeutic targets to prevent and/or slow the
progression of the disease. Greater than 90% of cases are caused by heterozygous loss-of-function genetic
mutations in exostosin-1 (EXT1) or exostosin-2 (EXT2), genes that encode enzymes responsible for the
biosynthesis of heparan sulfate (HS), which can lead to truncation of the HS chains and a consequent decrease
in HS levels in various tissues. Current evidence suggests that a decrease in HS content disrupts multiple
signaling pathways through which growth factors regulate the organization and function of chondrocytes in the
growth plate. Regardless of the mechanism, the primary defect is haploinsufficiency in EXT1 or EXT2, which
results in lower HS levels and leads to the formation of exostoses. To date, very little is known about the upstream
and downstream factors that regulate the expression and function of EXT1 and EXT2 in human cells.
Interestingly, there are also numerous patients lacking mutations in these genes, suggesting that heritable
alterations in other factors contribute to exostoses formation in MHE patients. Our previous studies have
revealed defined transcriptional and epigenetic regulatory mechanisms of HS biosynthesis in cells. The central
hypothesis of this proposal is that other factors exist that regulate EXT expression and are viable drug targets
for the restoration of HS levels and reduction of exostoses in MHE patients. Since a deficiency in HS is a key
component of MHE, we propose that over-stimulating the expression of the normal EXT allele to compensate for
the activity of the mutant allele could be a novel therapeutic approach to restore functionally normal levels of HS
in cells. The goal of this proposal is to leverage our experience in uncovering regulatory factors of HS formation
to adapt genome-wide screening assays to identify genes that control EXT1/EXT2 expression for drug target
discovery for MHE. To accomplish this goal, we aim to (i) adapt genome-wide screening assays to search for
novel factors that regulate EXT1 and/or EXT2 expression in human cells, and (ii) validate prioritized hits from
the screens in primary human chondrocytes using commercially available drugs and/or RNAi methods. The
successful completion of these aims will provide new pharmacological targets for enhancing EXT expression
and HS levels in cells and may also uncover previously unknown genes associated with MHE. Importantly, this
project will lead to future detailed hypothesis-driven studies that will bring us closer to finding a cure for this
debilitating disorder.

Public health relevance
PROJECT NARRATIVE Multiple hereditary exostoses (MHE) is a debilitating genetic disorder that affects one in every 50,000 children worldwide, and currently there are no approved therapies. The significance of this work lies in the development of novel screening assays to uncover new therapeutic targets for MHE and the potential for discovery of regulatory factors involved in heparan sulfate formation. This research is highly relevant to public health because the candidate genes identified in these studies represent new potential therapeutic targets for drug development to treat this orphan disease as well as other disorders where heparan sulfate formation goes awry.